Parental Influences on Emotion Regulation Pathways Among Youth with and without ADHD

Project Summary/Abstract
Attention-deficit/hyperactivity disorder (ADHD) is the most prevalent neurodevelopmental disorder (i.e., 11% of
youth). Traditionally, ADHD has been conceptualized as a disorder of cognitive functioning; however, work by
the applicant and others has emphasized the need to assess emotional functioning in order to better
conceptualize the disorder and tailor clinical care. Emotion dysregulation is a transdiagnostic factor that is often
present among youth with ADHD and can lead to poor academic, functional, and social outcomes. Importantly,
specific parental factors may serve as mechanisms of risk or resilience in the development of child emotion
regulation in ADHD. However, parental influences on child brain-behavior associations remain understudied in
this population. Thus, a multi-method approach is necessary to determine mechanisms that lead to the
development of emotion dysregulation and to identify the most at-risk youth. The primary goal of the proposed
research and training activities are to develop an independent program of research examining the influence of
parental factors on emotion regulation among youth with ADHD. Assessment of emotion dysregulation will be
conducted via behavioral report and resting-state functional connectivity between the amygdala and cortical
networks encompassing regions within the prefrontal cortex. The applicant is already well-versed in behavioral
and psychophysiological analysis of emotion regulation in ADHD, and has completed introductory training on
use of ABCD data. Thus, the proposed training plan highlights skill development in: 1) child neurodevelopment
and psychopathology, 2) fMRI data acquisition and design, 3) rs fMRI data analysis and interpretation, and 4)
professional development related to effective science communication. The proposed study seeks to examine
the effects of parental factors (e.g., poor monitoring/supervision, high conflict) on emotion regulatory systems
(i.e., behavioral, central nervous system). As part of the ABCD study, approximately 12,000 child participants
(an estimated 1,300 with ADHD; aged 9-10 years) completed behavioral reports of parental
monitoring/supervision and underwent an fMRI scan protocol during which resting-state functional connectivity
was measured. Parents completed a diagnostic clinical interview and reported on family conflict and child
dysregulation. This data will allow the applicant to address two primary aims: 1) Examine associations between
parental factors and child dysregulation among youth with and without ADHD, and 2) Examine associations
between parental factors, child resting-state functional connectivity, and child dysregulation among youth with
and without ADHD. The ultimate goal of this work will be to improve characterization of ADHD, to identify
potential treatment targets for the most at-risk youth, and to set the stage for longitudinal work on child brain
development as it relates to emotional functioning and functional outcomes. These training and research goals
will support the development of PI Feeney in obtaining a career as an independent researcher focused on
parental influences on child brain development specific to emotion dysregulation.

Public health relevance
Project Narrative Emotion dysregulation is a transdiagnostic factor that often leads to detrimental academic and social outcomes, particularly among youth with ADHD. The current project seeks to examine parental influences on emotion dysregulation via behavioral report and resting-state functional connectivity (rs-fc) between the amygdala and the default mode network (DMN), as well as between the amygdala and the frontoparietal network (FPN) among youth with and without ADHD. It is anticipated that results will aid in the identification of treatment targets for at-risk and resilient youth and mechanisms that contribute to the development of emotion dysregulation, as well as provide a foundation for later examination of longitudinal changes in youth brain development and functional outcomes.